Administrative Core

Research Program Administration (RPA) Core: Summary
The overarching goal of the FAMU RCMI Center application (2024-2029) is to establish an interdisciplinary
Center addressing minority health and health disparities. The Center will focus on efforts to pursue excellence
in basic and behavioral research on health disparities, training "next generation" minority biomedical and
behavioral scientists and supporting community partnerships that reduce racial health disparities. The overall
goal of the Research Program Administration (RPA) is to manage and coordinate the entire range of the
Center's activities, monitor its progress, and confirm that all the component's plans are implemented. The key
RPA members of the core consist of the PI, PD, Core Leaders, Research Projects PIs, External Advisory
Committee (EAC), Internal Advisory Committee (IAC), and External Program Evaluator. These units will work
as one team to implement the development of concept directions, monitor and review research activities, and
oversee the implementation of program initiatives. A critical function of the RPA is to implement and manage
the Career Enhancement Program (CEP), which will 1) Provide all investigators with the training and capacity
build-up to increase the use of Artificial Intelligence (AI) algorithms and techniques to analyze and interpret
large volumes of data more efficiently, leading to more accurate and insightful scientific discoveries and better
approaches in serving the communities. 2) Support the establishment and expansion of the quality of research
collaborations: The Center supports collaborations and partnerships between researchers within FAMU,
interdepartmental organizations, and investigators at external research centers nationwide and international
institutions, including RCMI institutions. The Center established and will continue its partnership with the Mayo
Clinic Comprehensive Cancer Center-Jacksonville, Florida partnership, providing an environment conducive
to career enhancement that would increase minority Junior Investigators' professional development and
retention in cancer research. Moreover, the Center will leverage the RCMI Research Coordination Center
(RCMI-CC) and the National Research Mentoring Program (NRMN) for investigator development and support.
3) Enhance the research skills of investigators through workshops and training. 4) Support faculty and staff
attendance at National conferences, workshops, and training in minority health and health disparities; 5)
Provide in-house scientific seminars. The RPA will work with the external program evaluator to evaluate the
FAMU RCMI Center proficiency, progress, and outcomes for specific aims and goals. In the evaluation plan,
inputting parameters will be utilized to reach data-driven decisions and steer the program's future direction,
optimizing efficiency, effectiveness, and success. Services provided by RPA will ensure investigators advance
their area of research experiences and expertise to focus on diseases that affect minority groups and reduce
health disparities.